Hematopoietic Regulation via GATA Switches

ABSTRACT
Our program to forge principles for how GATA factors act through chromatin to control development,
function and dysfunction of the hematopoietic system discovered conserved Gata2 enhancers (+9.5 and -77)
that ensure normal hematopoiesis. There were no reports of enhancers essential for stem cell generation or
progenitor fate decisions, and few examples of those vital for life. Human +9.5 variants resemble pathogenic
GATA2 coding variants in causing GATA2-deficiency syndrome involving immunodeficiency, myelodysplastic
syndrome (MDS), and acute myeloid leukemia (AML). -77 disruption also causes MDS/AML. Clinical centers
analyze +9.5 and -77 genetic variation. Outcomes from prior research included: (i) innovated a mouse model
mimicking epigenetic silencing in GATA2 deficiency syndrome. We demonstrated that GATA2 +9.5 variation is
conditionally pathogenic, requiring secondary alterations for pathogenesis; (ii) GATA2 deficiency reduces bone
marrow hematopoietic stem/progenitor cell (HSPC) responsiveness to extracellular signals and clinical stem cell
expansion regimens; (iii) GATA2-deficient progenitors upregulate innate immune machinery, disrupting cell fate,
and GATA2 replacement normalizes the ectopic response; (iv) We demonstrated that GATA2 coding variants
can be neomorphic, representing a paradigm-shift; (v) innovated rescue systems with multiomics to quantify
GATA2 activity and dissect a novel GATA2 deficiency syndrome variant, which yielded principles for GATA factor
function through chromatin; (vi) advised physicians nationally/internationally to interpret GATA2 variation.
Pathogenic variants, innovative systems, and multiomics will enable testing of how GATA2-regulated networks
govern HSPCs and suppress the onset of blood diseases in which therapies are critically needed. 1. Test
models to explain how hematopoietic progenitor genome function is established and maintained.
GATA2 activates a Cebpe enhancer to induce C/EBPε expression, promote granulopoiesis, and suppress
monocytic differentiation. We will test the hypothesis that GATA2 and C/EBPε operate collectively and
independently to establish progenitor genome activity that drives granulopoiesis. 2. Elucidate how a
pathogenic GATA2 germline genetic variant retains activity at a subset of GATA2-regulated loci. Our
analysis of the ramifications of the GATA2 pathogenic germline variant T354M revealed it retains a subset of its
activities. We will test the hypothesis that N-finger activity to counteract the impaired DNA binding of the
corrupted C-finger underlies the disproportionate importance of the N-finger for T354M. 3. Generate a human
GATA2 genetic curation system to unveil mechanisms and advance clinical genetics. Our assays
discriminate activities of human GATA2 variants from wild type GATA2. Although novel GATA2 variants continue
to emerge clinically, discriminating between pathogenic, conditionally pathogenic, and benign variants is often
inconclusive. We will test the hypothesis that activity metrics will generate a signature for a variant to advance
clinical genetic curation, and signatures will also unveil mechanisms.

Public health relevance
PROJECT NARRATIVE Elucidating mechanisms that regulate blood cell development is critical for devising therapeutic, diagnostic, and preventative strategies e.g., for GATA2-deficiency syndrome involving immunodeficiency and myelodysplastic syndrome, and innovating strategies to generate blood cells for transplantation therapies. We discovered GATA2-dependent mechanisms essential for blood stem/progenitor cell generation/function and identified how human genetic variation disrupts these mechanisms. These studies unveiled scientific paradigms and changed clinical practice, e.g., medical centers screen for genetic variation in enhancers we discovered, and physicians frequently consult with us to interpret clinical genetic variation.